Scientific Information Management and Literature-Based Evaluations for the DTT - Support for External Peer Review

A number of complex scientific reports are prepared under this contract on the Report Preparation project. Coordination of peer review includes managing a directory of scientific experts, conflict of interest screening for reviewers and companies with potential financial interest, and compiling documents for internal DTT record keeping. Peer reviews conducted under this project included Technical Reports on TCPP, black cohosh, and triclosan; a Research Report on trend tests for binary data; and an updated edition of the Handbook for Preparing Report on Carcinogens Monographs. Keywords: peer review.